ONCORNAVIRUS-ASSOCIATED CELL MEMBRANE ANTIGENS

Cats probably represent the most convincing species of mammals where retraviruses cause both leukemia and fibrosarcoma under natural conditions. We demonstrated that transformation-related antigens designated the feline oncornavirus associated cell membrane antigen or FOCMA and/or "gag-x" type proteins are expressed in cells transformed by feline sarcoma virus (FeSV) and FOCMA is also expressed in lymphoid tumor cells from feline leukemia virus (FeLV)-induced leukemias. In both cases these antigens are the target for a natural immunosurveillance response. In the proposed study we will analyze tumor cells from both induced and naturally occurring tumors, both leukemias and fibrosarcomas, to compare the FOCMA, "gag-x", and/or "x" type proteins in tumor cells to those we found earlier in in vitro transformed mink cells and cell lines. New field isolates of FeSV will be analyzed to see if their "x" or "sarc" related gene products are the same or different from the 3 known laboratory strains of FeSV. The proteins in metastatic tumor cells will be compared to those in primary tumors, regressor tumors will be compared to progressor tumors and tumors induced in non-feline species (dog, rat, hamster) will be compared to those induced in cats. Tumors induced by FeSV in different embryonic germ cell layers, such as melanomas and gliomas will be compared to fibrosarcomas and transformed fibroblasts, and naturally occurring tumors of types not usually associated with retraviruses (e.g. carcinomas) will also be examined for cross-reacting "x", "sarc", or FOCMA-type proteins. Fibrosarcomas and leukemias induced in cats with chemical carcinogens will be similarly examined for antibodies to these proteins and tumor bearing cats will be similarly examined to see which FOCMA or "gag-x" antigenic determinants induce the immunosurveillance-correlated immunity. Revertants of FeSV-transformed cells will be compared to the parent cells and the various classes of tumor cells will be examined for cellular processing compartmentalization, and membrane expression of the FOCMA/"gag-x" antigenic determinants.